ACL Reconstruction Rehabilitation with Exercise and Psychological Support

PROJECT SUMMARY
Anterior cruciate ligament (ACL) rupture is a common knee injury in sports that is usually surgically treated with
ACL reconstruction. Most patients expect to resume pre-injury sport participation after ACL reconstruction, yet
only 65% do, and up to 20% of those sustain another ACL injury. Fear of re-injury contributes to the sub-
optimal return-to-sport outcomes, giving it clinical importance and raising awareness of it. Yet a range of
negative (e.g., anger, fear/kinesiophobia) and positive (e.g., motivation, self-efficacy/confidence) psychological
responses are typical after ACL reconstruction. It is important to effectively manage psychological responses
because they impact behaviors, and in turn, outcomes. Standard ACL reconstruction rehabilitation strictly
focuses on exercise for knee impairments, and clinicians do not feel prepared to help patients manage their
psychological responses. Also, patients lack an understanding of psychological responses and helpful mental
skills. Clinicians and patients both require training to address the unmet need for psychological support in ACL
reconstruction rehabilitation. The objective of this study is to examine the efficacy of Rehabilitation with
Exercise and Psychological Support (REPS), a rehabilitation approach that integrates exercise with
psychological support provided by a clinician and patient training videos. The central hypothesis is that REPS
will facilitate better psychological response (Specific Aim 1) and knee function (Specific Aim 2) than Standard
Rehabilitation after ACL reconstruction. The feasibility, acceptability, and fidelity of implementing REPS will be
explored. This is a pilot randomized controlled trial of 60 patients with ACL reconstruction who receive REPS
or Standard Rehabilitation. Both groups will perform exercise per a standard rehabilitation protocol. REPS
clinicians (n=4) will receive didactic training and mentorship from the study team on a psychologically informed
practice approach for assessment and treatment, including patient-centered communication and cognitive-
behavioral techniques. Patients in REPS will receive training on mental skills to improve the psychological
response in videos created by the study team. Baseline testing will be immediately before the first rehabilitation
visit, and primary follow-up testing will be 6 months post-surgery, when rehabilitation typically completes. This
study will generate knowledge about a rehabilitation approach intended to provide psychological support to
patients during ACL reconstruction rehabilitation. The study has good potential to be impactful because it
targets an unmet need in ACL reconstruction rehabilitation that contributes to clinical outcomes. The REPS
intervention is innovative because it is administered within a clinical setting, engages both patients and
clinicians with pragmatic training methods, and could enhance patient-clinician communication to strengthen
therapeutic alliance for better rehabilitation adherence and outcomes.

Public health relevance
PROJECT NARRATIVE Soon after undergoing anterior cruciate ligament knee surgery, people often feel angry, sad, and frustrated, and may go on to experience fear and low confidence when it is time to play sports again. This study compares rehabilitation with exercise only to rehabilitation with exercise plus help from a clinician and educational videos to manage thoughts and feelings during recovery.